A DOSE RESPONSE TRIAL OF RO 40-5967 ADMINISTERED ONCE DAILY FOR HYPERTENSION

This is a multi-center, randomized, double-blind, placebo controlled trial to evaluate the safety and efficacy of a new calcium channel blocker administered once daily for the treatment of hypertension.